Decoding the Neural Foundations of Sexual Dimorphisms in Aggression: A Female-Centric Approach

PROJECT SUMMARY
Aggression, a fundamental behavior essential for survival and species propagation, is
ubiquitous across the animal kingdom. However, the neural underpinnings of innate
aggression, particularly in terms of sexual dimorphism, remain inadequately elucidated.
It is noteworthy that dysregulated aggression often surfaces as a symptom in various
neurological and psychiatric disorders, with a pronounced prevalence in disorders more
common among women, thereby underscoring a crucial gap in our scientific
understanding. In response to this challenge, our research is strategically focused on
the female Drosophila melanogaster to decipher the sexually dimorphic neural
substrates governing aggression. Leveraging our prior breakthroughs in identifying
neurons responsible for female-specific aggression, we have significantly enhanced the
understanding of the mechanisms encoding sex-specific primal behaviors. In the next
five years, we plan to employ the fly connectome for an extensive mapping of neural
circuits, aiming to elucidate how stress influences aggression via evolutionarily
conserved neuropeptides and to thoroughly investigate the developmental processes of
these neural circuits. Moreover, our research will delve into how these circuits are
disrupted in disease states associated with aggression dysfunction. Central to our
efforts is the investigation of the modulatory effects of stress and peptides on female
aggression and the assessment of the consequences of genetic modifications on key
functional genes. Our systematic approach to dissecting the circuitry underpinning
female aggression and identifying genes related to aberrant behavior is expected to
yield profound insights into the genesis of sex differences in neural mechanisms that
orchestrate social behaviors. This research program is poised to substantially advance
our understanding of sex differences in brain functions related to the regulation of
aggression across diverse species.

Public health relevance
PROJECT NARRATIVE Understanding the roots of aggression is vital for advancing our knowledge of brain function and behavior. Our research uses the Drosophila melanogaster model system to examine how the brain's integration of various signals influences aggression and how this differs between sexes. By shedding light on these sex-based genetic differences, we aim to fill a critical gap in our understanding and pave the way for innovative therapies for aggression-related conditions.